Comparison of cervical intraepithelial neoplasia 2/3 treatment outcomes with a portable LMIC-adapted thermal ablation device vs. gas-based cryotherapy

Project Abstract
Cervical cancer is a leading cause of cancer-related mortality among women in low- and middle-income
countries (LMICs). The World Health Organization recently released guidelines that endorse alternatives to
cytology-based screening, including HPV-based screening and visual inspection with acetic acid (VIA), which
will facilitate increased screening coverage and detection of curable precursors to cervical cancer. In order to
reduce the burden of cervical cancer, highly effective screening strategies must be combined with affordable
and accessible treatment of precancerous lesions. The standard treatment for cervical precancer, gas-based
cryotherapy, is often not accessible in LMICs because gas tanks are generally expensive, difficult to obtain,
and hard to transport. With the number of screening options increasing, an urgent need exists for a point-of-
care treatment technology that is accessible, portable, and inexpensive. We innovated the original
thermoablator, an existing cervical precancer treatment device with a probe heated to 100-120º C, for use on a
wider scale by customizing the device for LMICs in order to meet this need. This academic-industrial
partnership will compare this novel device to traditional CO2-based cryotherapy for the treatment of cervical
precancer in LMICs. The Specific Aims of this project are to 1) modify a novel thermoablation prototype adapted
and optimized specifically for treatment of cervical precancer in LMICs, determine a more nearly optimal patient-
centered protocol for treatment of high-grade precancer, demonstrate that the efficacy of LMIC-adapted
thermoablator is non-inferior to CO2-based cryotherapy for the treatment of cervical precancer, and determine the
cost-effectiveness of all evaluated therapeutic and post-treatment surveillance strategies. The hypothesis being
tested is that this novel device is non-inferior to CO2-based cryotherapy in terms of clinical validity and cost-
effectiveness. The research team has well-established relationships with leading regional organizations that
provide guidance to government-run cervical cancer prevention programs. Deployment of the LMIC-adapted
thermoablator to existing programs will not only improve program efficacy, but will also serve as a model for
adoption of this technology in the region. The results of this study will affect other research areas by serving as
a springboard to exploring treatment alternatives that are amenable to low-resource settings and thus will
reach the most vulnerable populations.

Public health relevance
Project Narrative Many countries have recently enacted cervical cancer screening programs, but even the most effective screening program will fail if treatment options are not widely accessible, especially in low- and middle-income countries (LMICs). We innovated the original thermoablator, an existing cervical precancer treatment device with a heated probe for use on a wider scale by customizing the device for LMICs. Our LMIC-adapted thermoablator prototype is portable and handheld, resilient under extreme conditions, compatible with unstable electrical systems, can run for a week with a rechargeable external battery, is capable of operation off a car battery when other power sources are not available, and will be further enhanced with a self-sterilization option, a rugged carrying case, and a user manual for midwives and nurses. Successful deployment of this innovative adapted thermoablator will result in a paradigm shift in how treatment of cervical precancer, defined as cervical intraepithelial neoplasia grade 2 and higher (CIN2+), is delivered in LMICs.